Regulation of the Serotonin Transporter Function by Integrins in the Mouse Brain

DESCRIPTION (provided by applicant): The presence of a comorbid depressive disorder increases risk for morbidity and mortality in patients with coronary heart disease. Serotonergic dysfunction is thought to contribute to mood disorders and is also a risk factor for heart disease, raising the possibility that altered 5-HT homeostasis contribute to comorbidity between neuropsychiatric and cardiovascular disorders. Recently, we discovered a physical and functional interaction between 5-HT transporter (SERT) and integrin β3 in platelets. While integrin β3 is essential for platelet function, SERT plays a prominent role in the modulation of neuronal 5-HT signaling. The integrin β3 polymorphism Leu33Pro is associated with cardiovascular disease due to enhanced integrin signaling and platelet aggregation. This β3 variant is also associated with hyperserotonemia in autistic patients, due to its upregulation of SERT surface expression and activity. Our preliminary studies indicate that integrin β3 is expressed presynaptically (as the dimer αVβ3), where it physically associates with SERT. Additional studies suggest that manipulation of αVβ3 signaling directly influences SERT function. These findings lead to my hypothesis that the SERT/ αVβ3 complex represents a critical and conserved facet of synaptic SERT regulation, mimicking its actions in platelets. This proposal seeks 1) to elucidate the physical basis by which αVβ3 influences SERT, 2) to establish the contribution of αVβ3-based activation to SERT regulation and 3) to understand the impact of Leu33Pro β3 coding variation on SERT function. In Aim 1, we focus on mapping the β3 binding domain in SERT utilizing biochemical and in vitro approaches, providing a route to the development of small peptides that can disrupt SERT/ αVβ3 interactions ex vivo. In Aim 2, we utilize small molecule αVβ3 ligands to delineate the influence of αVβ3 activation on SERT function ex vivo, as well as 5-HT clearance in vivo. In Aim 3, we determine the effects of the Leu33Pro β3 variant on 5-HT levels and SERT activity in both platelets and in the brain. We hypothesize that the expression of integrin Pro33β3 will lead to constitutively- elevated SERT function in platelets and brain. Together, these studies represent the first opportunity to examine the presynaptic impact of αVβ3 and help elucidate pathways supporting comorbidity between mental illness and cardiovascular disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project aims to understand how integrins modulate the serotonin system using molecular and biochemical approaches. As mood disorders are associated with impaired information processing, the association between a cell adhesion receptor and the major target for antidepressant therapy reveals a novel mechanism affected by mood disorders. The protein complex studied in detail in this proposal is also a common molecular feature of mood and cardiovascular disease and provides clues to understanding the comorbidities between the two disorders.